post-REcovery LIbEration From Oxygen in Exacerbated COPD (RELIEF)

Projects such as the American Board of Internal Medicine’s “Choosing Wisely” campaign emphasize the
importance of identifying and de-implementing ineffective, harmful and/or wasteful practices to improve the
quality and safety of delivered care. Among patients with chronic obstructive pulmonary disease (COPD),
oxygen has been shown to improve survival among a specific subset of patients with severe resting
hypoxemia. The provision of oxygen therapy has been extrapolated to other populations leading to the
prescription of oxygen to patients with COPD who do not have an evidence-based indication for its use. For
example, oxygen is frequently prescribed upon discharge from hospital after an exacerbation of COPD, then
continued indefinitely, resulting in patients who become habituated to having oxygen readily accessible.
Published in 2016, the Long-Term Oxygen Treatment Trial (LOTT) demonstrated that the use of supplemental
oxygen conferred no benefit to patients with COPD who have moderate resting or ambulatory hypoxemia. In
addition to being ineffective in this patient population, supplemental oxygen can pose risks of harm, such as
the potential for fire or injury due to falls caused by entanglement in oxygen tubing. It is in this setting that we
now have an opportunity, as well as a challenge, to learn how best to improve care quality by de-implementing
a therapy that has no demonstrable benefit, is not without risk, but is deeply entrenched in clinical practice. To
address this knowledge gap, our proposed study aims to use a mixed-methods approach to inform VA about
their current practices for prescribing oxygen therapy to patients with COPD, as well as to identify anticipated
barriers and facilitators to its de-implementation among patients in whom it has been shown to be ineffective.
To achieve these goals, we will first identify a nationwide cohort of Veterans discharged with supplemental
oxygen after hospitalization for a COPD exacerbation and identify patient-, clinician- and system level factors
associated with appropriate reassessment of oxygen need within 90 days of discharge. We will then identify a
range of high- to low-performing sites in regards to timeliness of oxygen need reassessment. Using a
sequential mixed methods approach incorporating quantitative survey collection and in-depth qualitative
interviews, we will elicit patient and clinician perspectives on the discontinuation of supplemental oxygen
across a range of the high- and low-performing sites as well as at the sites of our planned intervention. Using
these initial results, we will develop, refine, and test a patient-, organizational-, and operational partner-
informed pilot intervention to increase value-based care by decreasing inappropriate oxygen use. We will
randomize 50 patients at two VA sites (VA Puget Sound and Bedford VA) to receive usual care or our de-
implementation intervention. In addition to assessing feasibility and acceptability of the intervention, we will
assess secondary outcomes, including changes in functional status and symptoms over 12 weeks. If
successful, this study has the potential to lead to a larger randomized control trial of our de-implementation
intervention throughout VA. In addition, the results of this study could be extended to other clinical contexts to
inform interventions designed to de-implement therapies that are pervasive in clinical practice but of low-value.

Public health relevance
For VA, oxygen treatment is expensive and is commonly delivered to patients with COPD at discharge after a hospital admission for exacerbation. COPD is the second most common medical reason for hospital admission within VA, resulting in more than 20,000 hospitalizations annually. Recently published data suggests that much of the oxygen provided to patients does not improve outcomes. Thus, the post- exacerbation recovery period is a prime target for interventions designed to liberate patients from oxygen who will not benefit. In addition to providing us with an enhanced understanding of VA’s current practice for prescribing oxygen to patients with COPD, this study will characterize patient and clinician perspectives on the discontinuation of oxygen and use them to refine a pilot intervention to de-implement oxygen therapy in those unlikely to benefit from its use. Our study provides an important opportunity to better understand how best to de-implement a costly and prevalent practice that adds no benefit and creates potential for patient harm.